Supplement: USING OPTOGENETICS TO DISSECT THE ROLE OF REDOX SIGNALING DURING C. ELEGANS AGING

PROJECT SUMMARY The model that reactive oxygen species (ROS) cause age-related degeneration has been challenged by the observation that endogenously produced ROS are essential second messengers sufficient to extend lifespan in many model organisms. Seemingly contradictory results and regulatory models derived from manipulations of global ROS levels are commonly framed as the `antioxidant paradox' of aging12. A key observation is that long- lived mutant animals of several model organisms, including C. elegans, often require ROS for lifespan extension, which seems contrary to the free radical theory of aging that posits ROS are deleterious. We propose to address this paradox in the context of C. elegans longevity and aging. We hypothesize that the location and level of redox signaling is the critical determinant of whether ROS promote lifespan extension or cause age-related degeneration. To test this hypothesis, we will utilize an innovative new technique, optogenetic production of ROS, to systematically explore how the location, timing and intensity of intracellular ROS production affects C. elegans lifespan, healthspan and transcriptional programs. Aim 1 will define the locations, both at the subcellular and tissue level, that are sufficient for C. elegans lifespan extension. Aim 2 will determine how spatial regulation of ROS production controls activation of lifespan extending transcriptional programs. The ability to precisely control ROS production with optogenetics will enable us for the first time to disentangle how redox signaling networks functionally contribute to complex phenotypes such as aging. Successful completion of these aims will have a significant impact by elucidating the biology of redox signaling that influences lifespan and suggesting strategies to improve development and application of antioxidants as possible therapeutics for aging and age-related disease.

Public health relevance
PROJECT NARRATIVE Reactive oxygen species (ROS) play important roles in aging and have been proposed to both cause and ameliorate age-related degeneration. This proposal will use optogenetics to precisely control the location, timing and intensity of ROS in C. elegans, a relevant model of animal aging. We will systematically determine how these specific ROS parameters affect lifespan, healthspan and transcriptional programs. The elucidation of how subcellular and tissue-level ROS production affects age-related degeneration may suggest new approaches to human aging.